Endocannabinoid Control of Cholinergic Transmission and the Pursuit of Reward

PROJECT SUMMARY
Studies using animal models and human subjects have provided evidence for the importance of acetylcholine
(ACh) in cognition. The medial septum-diagonal band of Broca complex (MS) serves as a significant source of
cholinergic innervation to the hippocampus (HC), a brain region important for memory processes. Cannabinoid
type 1 (CB1R) receptors, the main negative feedback modulators of activity in the brain, are expressed on
cholinergic HC terminals, where they fine-tune ACh-dependent behavioral responses. While the involvement of
ACh in encoding of spatial information and memory formation is well-established, emerging evidence suggests
that cholinergic signaling in the HC is also recruited for reward seeking. The anatomical framework that will be
investigated here is a neural substrate involved in the generation and modulation of theta oscillations in the HC
and in the computations that give rise to working memory (WM) and associative learning necessary for the
motivated pursuit of rewards. Our exciting preliminary data supports an interaction between CB1R and ACh in
WM, as animals with a conditional deletion of CB1R specifically on ACh terminals arising from the MS
outperform their wild-type litter mates in an instrumental delayed non-match-to-sample (DNMTS) task.
Surprisingly, our preliminary findings also show that these animals have enhanced motivation for natural
rewards observed in progressive ratio (PR) and behavioral economics (BE) tasks. Because physiological data
suggests that high ACh levels may set appropriate dynamics for sustained activity and theta oscillations in HC,
we hypothesize that CB1R deletion from cholinergic terminals in the HC enhances the broadcast of theta
oscillations to executive regions such as the prefrontal cortex (PFC) or limbic-motor integrators such as the
nucleus accumbens (NAc), thereby increasing performance. We will test this hypothesis across two different
domains: 1) WM and 2) motivation. This has never been directly tested because doing so requires selective
modulation of CB1R activity and signaling at anatomically precise brain loci time-locked to behavior as well as
rapid measurement of ACh dynamics, which will be achieved with the use of a fluorescent sensor paired with
photometric detection. Specific optogenetic control of ACh release and HC theta power will allow explicit tests
of current hypotheses of CB1R-mediated modulation of coordinated neuronal activity between HC, PFC and
NAc required for behavioral performance. Thus, through the study of interactions between cholinergic and
CB1R signaling, the present proposal will provide novel therapeutic strategies aimed at recovery and gain of
function in conditions characterized by memory loss and diminished motivation.

Public health relevance
NARRATIVE Disorders of memory loss and lack of motivation, such as Alzheimer's disease and Lewy Body dementia, are becoming increasingly prevalent in the general population. Here we will explore the role of the endogenous cannabinoid system as a modulator of cholinergic tone for a broad spectrum of conditions involving compromised motivational drive and loss of memory. Therefore, heightened understanding of the physiological consequences of acetylcholine and endogenous cannabinoid interactions will allow targeting of specific receptor effects in the treatment of these disorders.